New mechanisms of cardiac ryanodine receptor dysfunction during oxidative stress: the role of intersubunit cross-linking

PROJECT SUMMARY/ABSTRACT
Calcium (Ca) release through the ryanodine receptor (RyR) Ca channel is essential for regular heart
contraction. Defects in RyR regulation cause an imbalance in intracellular Ca homeostasis in a variety of
cardiac diseases. The most common cardiac pathology, such as myocardial infarction, is associated with
oxidative stress. RyR contains a large number of cysteine residues that link oxidative stress and Ca
homeostasis. However, the pathologically relevant cysteines within RyR remain largely unknown. As a result, the
mechanisms of RyR dysfunction during oxidative stress and myocardial infarction are not fully understood. This
delays our progress in designing effective therapeutic interventions that can improve Ca homeostasis during
ischemic heart diseases. The main goal of this proposal is to define the molecular mechanisms of RyR
dysfunction during oxidative stress and myocardial infarction. We have recently discovered that oxidative stress
activates RyR by forming disulfide bonds between two neighboring subunits: the intersubunit cross-linking. It
appears that only two cross-linking cysteines play a critical role in the RyR response to oxidative stress. In this
proposal we will test the hypothesis: the intersubunit cross-linking is the principal redox modification of
RyR responsible for Ca dysregulation during oxidative stress and myocardial infarction. To test this
hypothesis, we have developed a transgenic mouse model with a unique RyR2 knock-in mutation that protects
RyR from the intersubunit cross-linking. In Aim 1, we will define molecular mechanisms of RyR dysfunction
induced by the intersubunit crosslinking. We expect to show that the cross-linking activates RyR2 by promoting
longer channel openings. Such alteration of RyR function increases Ca leak and triggers pro-arrhythmogenic Ca
waves. We expect to show that RyR mutation that protects the channel from the cross-linking will normalize RyR
activity, reduce Ca leak, and prevent Ca waves during oxidative stress. In Aim 2, we will define the critical role of
the RyR intersubunit cross-linking in Ca dysregulation and contractile dysfunction during myocardial infarction.
We expect to show that RyR mutation that protects the channel from the crosslinking will normalize cardiac Ca
regulation and improve myocardial contraction in the infarcted heart. We will also test whether selective
pharmacological interventions that stabilize RyR at the intersubunit cross-linking region can reduce Ca leak and
prevent Ca waves during oxidative stress and myocardial infarction.

Public health relevance
NARRATIVE Heart function vitally relies on well-controlled intracellular calcium regulation. Defects in this regulation can cause life-threatening arrhythmias and contractile dysfunction. This research proposal is relevant to public health, as it holds the promise to form a new mechanistic basis for future therapeutic strategies that can improve heart function in a wide range of cardiac pathologies, including myocardial infarction and heart failure.